SAFETY &EFFICACY OF LOSIGAMONE IN INADEQUATELY CONTROLLED SEIZURES

The purpose of this study is to compare the safety of two dosage levels of Losigamone with results obtained in placebo-treated patients.